EPIDEMIOLOGY OF ACQUISITION OF RESPIRATORY PATHOGENS IN PATIENTS WITH CF

This NIH funded research is in conjuction with the U of WI-Madison. The purpose of this study is to determine risk factors for the acquistion/colonizatin of respiratory tract of children with CF. The hypothesis to be tested is that exposure during clinic visits of young children with CF to older patients who are colonized with Pseudomonas significantly increases the risk of acquistion of this organism in early childhood.